Microphysiological Systems World Summit

Project Summary:
Microphysiological systems (MPS) comprise a number of bioengineering breakthroughs that reproduce organ
architecture and function in vitro. Fueled by stem cell technologies, a broad variety of especially human models
and test systems have emerged, which make relevant experimental tools broadly available through international
and multi-disciplinary collaborations. Conference(s) (series) are a key tool to form a community and accelerate
scientific developments, their implementation and global harmonization. They provide an overview on the state-
of-the-art in such dynamic and diverse fields, enabling transfer learning. A global conference on MPS was
identified by opinion leaders in the field as a key step forward in the maturation and harmonization of the area.
More than 30 International organizations and companies have teamed up for this proposal to initiate a series
of annual MPS World Summits to present the latest scientific achievements, discuss the advances and
challenges, and enable communication between young and newly interested scientists and pioneers of the MPS
field. The conference should be a kick-off for an International MPS Society. Bringing together the stakeholders
from different areas (developers, life scientists, regulators and regulated industry) will allow us to move these
breakthrough technologies faster toward reliable, standardized, validated and regulatory accepted tools in
biomedical sciences. The conferences are planned for New Orleans in May 2022 (hosts Don Ingber & Thomas
Hartung), Europe late 2023 (likely in Berlin hosted by Uwe Marx & Marcel Leist) and on the US west coast, late
2024, to reach out more to the Asia-Pacific region (hosted by Elaine Faustman & Thomas Neumann). Each
conference will cover the broader aspects of MPS development and application to map the state of this
technology and its challenges and opportunities.

Public health relevance
Project Narrative: A series of global conferences on microphysiological systems is started to bring all stakeholders as well as newly interested and young investigators together to promote the development and application of this technology, to facilitate its expanded scientific and regulatory use and to start an international MPS society.